Research Design, Compliance & Data Management Core

TRANSCEND-Research Design, Compliance and Data Management Core
Core Summary
Clinical and transla�onal (C&T) research beneﬁts from strong biosta�s�cal, clinical, and data management support. With
this understanding, the Research Design, Compliance and Data Management Core (RDCDC) strives to be the “go-to”
resource for the methodological, sta�s�cal, and clinical data management needs of TRANSCEND inves�gators. To
accomplish this goal, we have four aims: 1) providing comprehensive sta�s�cal support; 2) overseeing project
management and clinical opera�ons ac�vi�es; 3) providing data management support, and 4) cul�va�ng training and
connec�ons among researchers. To achieve these aims, we have established an integrated RDCDC that provides
exper�se in research methodology, biosta�s�cs, epidemiology, experimental design, biomedical informa�cs, project
management, data management, and database access. To beter serve clinical and transla�onal researchers, the RDCDC
has several special ini�a�ves, which include �mely feedback, access to high-speed compu�ng, clarity in regulatory
requirements, promo�on of publicly available datasets, and development of sta�s�cal training material that responds
directly to researcher educa�onal requests. The RDCDC brings together talented members to support the technical and
research training needs of researchers. This is especially important in a rural state that has historically lacked major
infrastructure for C&T research. The RDCDC not only serves as a vital resource for current inves�gators but also shapes
the founda�ons for future inves�gators.